Americas Association of Sarcoidosis and Other Granulomatous Disorders 2024: The Art of Working Together for Progress

PROJECT SUMMARY/ABSTRACT
With an emphasis on the integration of basic, translational, and clinical approaches, the Americas Association
of Sarcoidosis and Other Granulomatous Disorders (AASOG) 2024 Scientific Conference, entitled “The Art of
Working Together for Progress,” will focus on a central question: how can multi-disciplinary care, research,
and education in sarcoidosis improve patient outcomes, reduce health disparities, and advance disease
understanding? To address this central question, the program is organized into a series of thematic sessions
focusing on (i) the development of multi-disciplinary teams and training multi-disciplinary experts, (ii) health
disparities in sarcoidosis (iii) clinical trials and outcome selection, (iv) precision medicine in sarcoidosis and (v)
advanced disease management. The conference aims to accomplish the following objectives: 1) To establish
the only large forum in the western hemisphere to present ongoing research and multidisciplinary collaboration
of investigators specifically focused on the pathogenesis and treatment of sarcoidosis. 2) To stimulate
interactions between the scientific fields of immunology, molecular biology, epigenetics, genetics, genomics, and
public health to identify emerging, shared interests that may lead to the performance of more efficient and
productive research. 3). To inspire interactions between the disciplines and multidisciplinary team members
within sarcoidosis, including pulmonary, cardiology, rheumatology, ophthalmology, and neurology, to improve
patient outcomes, develop management strategies, and reduce health disparities. 4) To challenge and stimulate
the scientific interests of trainees, attracting a new generation of junior investigators into the field of sarcoidosis.
The AASOG 2024 Planning Committee has identified outstanding thought leaders in sarcoidosis as well as
selected experts from outside the field to achieve the mission of improving the collective clinical and scientific
approach to sarcoidosis. Each session will consist of several presentations followed by dedicated time for
discussion to stimulate collaboration and innovation. A major thematic focus of the conference is addressing
health disparities in sarcoidosis through a multidisciplinary, collaborative approach. The program aims to achieve
this by continuing AASOG’s commitment to diversity and inclusivity with conference faculty including
approximately 50% women, 20% from underrepresented racial/ethnic groups, 17% early career faculty, 17%
non-physician team members, including 4 patients. Participation of trainees and junior faculty is facilitated by an
oral abstract session, poster sessions, and a clinical case discussion session. Networking and collaboration
opportunities will include meal and coffee breaks, a structured speed mentoring event, a dinner reception and a
breakout group session. The conference will conclude with a high-level summary and review of the impact and
common themes from the conference to identify key future directions for basic, translational, and clinical research
in sarcoidosis. Attendees will receive Continuing Medical Education credit and can attend in person or virtually
to facilitate participation and dissemination of knowledge in the field.

Public health relevance
PROJECT NARRATIVE A diagnosis of sarcoidosis carries significant morbidity and can be associated with end-stage pulmonary fibrosis, cor pulmonale, and pulmonary hypertension as well as sudden death, neurologic, and other solid organ impairment. Sarcoidosis is also a disease that disproportionately affects African Americans in the US and is associated with significant health disparities. Taking a multi-organ, interdisciplinary approach, the Americas Association of Sarcoidosis and Other Granulomatous Disorders (AASOG) 2024 Conference will stimulate interactions between the scientific fields of immunology, molecular biology, epigenetics, genetics, genomics, and public health to promote scientific advances through more efficient and productive research and ultimately improve global health in sarcoidosis.